Social experience dependent modification of gene regulation and circuit function

Social isolation has profound effects on animal behaviors and physiological responses. Loneliness has been
linked to various detrimental effects on the brain, including an increased incidence of neuropsychiatric disease
and dementia. However, the precise molecular and neural mechanisms through which social isolation
influences brain health and behaviors remain elusive. Recent data suggest an immune and neuroinflammatory
basis for precipitating neuropsychiatric and neurodegenerative disorders. We hypothesize that transcriptional
changes in immune gene expression and immune state in the brain contribute to social experience-dependent
modulation of behavior. Consistent with this hypothesis, our preliminary studies have identified alterations in
immune gene expression and the blood-brain barrier-a critical immune structure in the brain-in response to
social isolation. This proposal aims to uncover the underlying transcriptional, cellular, and circuit mechanisms
that mediate the impact of social isolation on brain immunity and behavioral responses. We will test the
hypothesis that distinct pheromone circuits communicate social signals to the brain, reprogramming
transcription, immune gene expression, and immune responses to modulate courtship behaviors with social
experience. First, we will identify the neurons and glia that express the socially regulated immune genes in the
central brain and the pheromone circuits modulating their expression with social experience. Next, we will
determine how the immune state of the brain changes with social experience, along with identifying the
pheromone circuits mediating these effects. Finally, we will investigate whether social modulation of immune
gene expression and immune state contributes to social experience-dependent modulation of courtship
behaviors. We expect the results from our studies to have immense potential for the development of strategies
to mitigate the adverse effects brought about by social isolation on brain health and behavior.
Project Summary/Abstract

Public health relevance
This project aims to offer new insights into the intricate connections between immune gene expression, behavioral responses, and immune responses in the brain, and how they are influenced by social experience. I anticipate that the experiments proposed here will identify genes and circuits contributing to the social experience-dependent regulation of neuroimmune interactions. These findings would provide new insights into how social isolation leads to immune dysfunction in the brain, contributing to alterations in brain structure, function, and behavioral responses. Thus, our studies will have important implications for understanding and developing creative and cost-effective therapeutic approaches to mitigate the manifestation of neuropsychiatric and neurodegenerative disorders. Project Narrative